Genomic Surveillance of SARS-CoV-2 in the State of Delaware

ABSTRACT
The virus responsible for causing the COVID-19 pandemic, SARS-CoV-2, has a diverse genomic
landscape that is quickly evolving. It has been challenging for the medical and scientific
community to keep up with numerous variants and their association with clinical outcomes. The
impact of the pandemic in the United States has been devasting for the healthcare industry and
economic infrastructure. Enhanced genomic surveillance efforts are needed to be better
understand how transmission patterns and virus evolution affects clinical outcomes. This project
proposal focuses on increasing SARS-CoV-2 genome sequencing in pediatric patients and
disseminating the demographic analysis for all samples sequenced in the State of Delaware
Public Health Laboratory (>10,000). This project is leveraging key expertise in a collaborative
effort between the top pediatric hospital in Delaware, Nemours, and the State of Delaware Public
Health Laboratory.

Public health relevance
PROJECT NARRATIVE COVID-19 is known to have variable impacts on individuals based on age, race, socioeconomic status and co-morbidities as well as viral variant. However, each infected individual has a unique viral profile due to the rapid evolution of the SARS-COV-2 genome although little is known about how this effects disease outcomes, particularly in children. This proposal expands SARS-COV- 2 genome sequencing in Delaware, an IDeA state, and seeks to understand whether SARS-COV- 2 sequence variations within an individual affect clinical presentation of COVID-19, particularly in children.